T Cell Homeostasis

Summary
The durability of diverse forms of T cell memory is critical for effective immunity against various pathogens, and
can be harnessed for cancer immunotherapy. Yet the signals that maintain T cell memory, and preserves the
identity of distinct memory subsets, are incompletely understood. In particular, while there is considerable data
suggesting that the cytokines IL-7 and IL-15 are important for preservation of memory CD8+ T cells, there are
discrepancies in the literature that suggest this does not apply to all subpopulations of memory cells, or to all
infectious systems. We believe some of these discrepancies arise from experimental procedures that do not
accurately evaluate established memory T cell homeostasis (but which are conditioned by effects on memory
generation). To test this, in Aim 1, we will use temporally inducible gene knockout strategies to eliminate
sensitivity of T cells to IL-7 and/or IL-15, after the memory populations have been generated. We will examine
these models in both steady-state T cell homeostasis and in the response to “bystander” infections. In Aim 2,
we investigate the stability of two major classes of memory T cells – recirculating memory cells (“TMM”) and
tissue-resident (“TRM”) cells. Each has different functional roles and distinct trafficking patterns. Based on
published and preliminary studies, we will explore the role of the transcription factor KLF2 in controlling the
“identity” of TMM vs TRM (and whether changes in KLF2 expression – by genetic manipulation or in response to
statin drugs - will cause interconversion of TRM and TMM). We also investigate novel findings which indicate that
expression of the egress factor S1PR1 (which is a gene regulated by KLF2) is critical for recirculation of TMM
produced following some infections but not others, with consequences for therapeutic strategies to restain
pathogenic T cell responses by targeting S1PR1. Again, these models will harness inducible gene
knockout/expression models, as well as pharmacological treatments. Together, these studies represent a
novel and highly significant investigation into the basis for durability in the diverse subpopulations of memory
CD8+ T cells, with implications for how this can be manipulated for therapeutic goals.

Public health relevance
Narrative A key feature of the immune system is the generation of “memory”, which allows us to become “immune” after the first encounter with a pathogen or vaccine, successfully fending off future encounters with that pathogen. One population of memory cells, called memory T cells, come in a variety of “flavors” which exhibit distinct functional properties – one major subdivision is into memory T cells that patrol the body incessantly (recirculating memory cells) and ones that stay in tissues long-term (resident memory cells) , which can promptly respond to local infections. Key to immune “memory” is that these T cell populations last long-term (decades in humans, years in mice) and preserve their distinct “identities” (e.g. as recirculating or resident cells): however, while this has been a topic of considerable interest for decades, discrepancies in published studies need to be resolved in order to determine how memory T cells are maintained. We will use sophisticated genetic models, as well as pharmaceutical treatments, to accurately determine how distinct subsets of memory T cells are sustained by the soluble factors (called cytokines) IL-7 and IL-15 and how the “identity” of recirculating and resident memory cells is maintained by expression of a DNA binding protein called KLF2 and some of the genes it regulates. These studies will give us an improved understanding of how memory T cell maintenance is maintained and identify areas of potential therapeutic intervention to enhance or reshape the T cell memory population for clinical goals.